Brain and Cognitive Development in the PASS Cohort: The Impact of PrenatalAlcohol Exposure

This is a competitive renewal application for R01-AA025653. Over the last 6 years, we have conducted
neuroimaging studies in over 400 South African (SA) youth [8-12-years-old; ~300 with prenatal alcohol
exposure (PAE) and ~100 non-exposed Controls (NC); 50% girls] from the Prenatal Alcohol, SIDS and
Stillbirth (PASS) prospective birth cohort. The PASS cohort is comprised of ~6,000 SA children (born 2008-
2014; now ~8-15-years-old) whose mothers reported on drinking behavior during pregnancy. With pseudo-
random selection criteria for the PAE participants recruited during the 1st funding period, the quantity of total
drinks during pregnancy was (on average) quite low (range: ~1-611 drinks, M = 27.6, SD = 59.2 ). During this
renewal period, we have the opportunity to extend recruitment to over-sample youth with much higher PAE
quantities (range: ~32-817 drinks, M = 123.9, SD = 110.8). For renewal, we have developed a novel cohort-
sequential cross-sectional/longitudinal study design, in which we would bring back ~50% of participants
recruited during the 1st funding period (~150 PAE, ~50 NC) for longitudinal assessment of brain, cognition, and
facial morphology (BCF), plus recruitment of ~250 new PASS participants (~200 PAE, ~50 NC). This will
permit 1) recruitment of more highly exposed PAE participants to span the range of exposure, 2) study of a
broader age range across adolescence among PAE and NC from 8 to 17 years during which dramatic brain
development continues, and 3) utilization of data collected during the 1st 6 years both in the longitudinal
component and with newly recruited participants in the cross-sectional component. Notably, most children with
heavy PAE experience greater early life adversity than NC children, and early intervention is believed to be key
in attenuating PAE-effects, the latter of which may depend, in part, on understanding the impact of quantity,
frequency and timing (QFT) and early life experiences. Our history of productive team-work and existing
infrastructure, coupled with experienced staff and collaborators in South Africa over the last 6 years, bode well
for renewal, putting us in an exceptional position to further understanding how QFT of PAE independently, or
interactively, impacts associations between (1) brain and cognition/behavior, (2) brain and early life
environment, and (3) brain and facial morphology as function of environmental/maternal factors. We will use
identical measures of brain structure/function, 3D facial imaging, cognition (WISC-V), early life experience
(e.g., maternal age, nutrition, parity, mental health, substance use both perinatally and currently) and
environmental risk factors (e.g., multiple measures of SES, access to resources, stress), measured perinatally
and during childhood. Both cross-sectional and longitudinal quantitative measures from 3D facial imaging will
be utilized in parallel with neuroimaging and cognitive assessments. Using the entire range of PAE, we expect
independent and interactive (e.g., quantity by timing) effects of QFT on brain/cognition/face associations, with
the largest effects driven by quantity, followed by frequency, and then timing of PAE.

Public health relevance
Public Health Relevance Fetal alcohol spectrum disorder (FASD) is completely preventable, yet remains among the top 3 known causes of intellectual disability with an estimated prevalence of 2.4-4.8% in the US that accrues costs to society greater than $3 billion annually. Most children with FASD experience greater early life adversity compared to non-exposed children, yet little is known about how the perinatal, infant and early childhood environment interacts with the effects of prenatal alcohol exposure (PAE) on brain and cognitive development. Capitalizing on the large prospective cohort study of children in South Africa where rates of maternal alcohol consumption are high, and in which mothers reported on alcohol consumption during and throughout pregnancy, will allow us to address significant gaps in knowledge about the impact of PAE across the full range of maternal drinking patterns on later brain and cognitive development, as well as interactive effects with early life environment.